Telomere length analysis in the CALERIE trial

PROJECT SUMMARY
Long-term caloric restriction (CR) is one of the most effective and well-studied intervention to extend both
average and maximum life spans in a variety of species, from yeast to primates. Recent evidence from the
Comprehensive Assessment of Long term Effects of Reducing Intake of Energy (CALERIE) suggests CR
slows biological aging in humans, as measured by an algorithm applied to blood chemistry data. The
mechanisms through which CR affects healthy lifespan involve a complex array of molecular pathways, from
reduced inflammation and oxidative stress, improved mitochondrial function, enhanced autophagy and
increased stress resistance. Notably, the aforementioned mechanisms are implicated in telomere length
regulation. Yet, whether CR slows biological aging as indicated by telomere length, has not been addressed,
as well as the role of inflammation and oxidative stress in the hypothesized mechanism. Understanding the
molecular pathways by which CR increases healthspan could pinpoint new targets for anti-aging therapies.
Here we will assay leukocyte telomere length (LTL) in CALERIE to test whether CR is associated with
decreased LTL erosion as compared to the ad libitum control. LTL assays will be conducted using both the T/S
ratio and the absolute qPCR assay, and communicated based on new qPCR reporting guidelines set by the
Telomere Research Network. Further, making full use of the repeated measures of LTL obtained across the
trial, we will examine when, during the two-year span, the differences in LTL emerge (e.g., earlier or later).
Utilizing CALERIE biorepository, we will further test whether the hypothesized reduced LTL erosion in the CR
arm is mediated by reduced level of inflammation and oxidative stress. In Aim 1a, intent-to-treat analysis will
test whether CR is associated with reduced LTL erosion over 24 months, compared to the ad libitum control.
Aim 1b will conduct dose-response analyses and investigate whether intervention effects are mediated by
weight loss, and examine when, earlier or later in the 24-month trial, the CR effects on LTL change emerge.
Aim 2 will test whether CR is associated with LTL changes over 24 months through reduced levels of
inflammation at 12 and 24 months (factor analysis of CRP, ICAM1, IL1β, IL6, IL8, Leptin, MCP1, and TNF-α),
and reduced levels of oxidative stress at 12 and 24 month (factor analysis of F2‐isoprostanes—iPF(2α)‐III,
2,3‐dinor‐iPF(2 α)‐III, iPF(2 α)‐VI, and 8,12‐iso‐iPF(2α)‐VI). This innovative work will determine from a first-ever
randomized trial design if human caloric restriction slows cellular aging as measured by telomere length.
Findings will help generate new knowledge about CR mechanisms in humans at the cellular level. The data
generated will be shared with the CALERIE Biorepository upon completion of assays for investigators use.

Public health relevance
PROJECT NARRATIVE The proposed project will conduct new telomere length assays of stored biospecimens from the CALERIE trial, the first ever randomized human trial of long-term caloric restriction. We will use new telomere length data to test if caloric restriction slows the rate of cellular aging in humans, and explore putative biological mechanisms. Overall the project will advance efforts to improve mechanistic understanding of how caloric restriction influence telomere length in humans, which could pinpoint new targets for anti-aging therapies.